Immunotherapy for Factor VIII Inhibition in Hemophilia A

Hemophilia A is one of the most common X-linked recessive disorders, affecting one in 5,000 male births
globally. Intravenous FVIII replacement is the standard of care therapy and resistance develops to FVIII in 20–
30% of patients with severe disease from the production of anti-FVIII antibodies (inhibitors). Clinical immune
tolerance induction protocols to eliminate inhibitors are not effective in all patients, and there are no approved
prophylactic protocols to suppress FVIII-specific antibody responses. Recent findings have reported that
tolerance to replacement FVIII protein is strongly modulated by T regulatory cells (Treg).
Teichos Laboratories proposes to evaluate TL-003, a unique immune response attenuator from its platform
of totally synthetic peptidoglycan (sPGN) molecules for tolerance induction against Factor VIII resistance in
Hemophilia A. TL-003 treatment produced anti-inflammatory activity at low doses in preclinical models. These
responses were associated with in vitro findings that TL-003 produces no stimulatory signal from TLR2, unlike
natural PGN and other immune response activator sPGNs. TL-003 is taken up avidly by monocyte-derived
dendritic cells (DC). TL-003 does not up-regulate costimulatory molecules on antigen presenting cells (APCs)
and treatment of peripheral blood mononuclear cells (PBMCs) stimulates production of the anti-inflammatory
cytokine, IL-10. Abrogation of TLR2 signalling, diminished up-regulation of costimulatory molecules, potential
activation of Treg, and in vivo anti-inflammatory activity provide a compelling rationale to evaluate an immune
response attenuator adjuvant (TL-003) combined with a recombinant therapeutic protein antigen (FVIII) in a
tolerizing vaccine therapy for Hemophilia A resistance.
TL-003 is synthesized by a chemoenzymatic process that produces otherwise inaccessible single-strand
bacterial cell wall peptidoglycan. This synthesis is efficient, scalable, and controllable, producing homogenous,
soluble, single strand, uncrosslinked PGN with molecular weight in the antibody range. Given the molecular
properties of sPGN, scale-up production and chemical manufacturing issues are addressable using processes
similar to those employed in standard pharmaceutical development.
The Specific Aims of this proposal are to establish preclinical parameters that will support clinical
development of TL-003 as a new tolerizing vaccine adjuvant to treat Factor VIII resistance in Hemophilia A.
We will 1) prepare sPGN test articles and 2) determine how TL-003 induces peripheral (p) Treg via modulation
of antigen presenting cells (APC) and 3) evaluate the effects of this new synthetic immune response attenuator
on the production of FVIII inhibitors in an established mouse model of Hemophilia A.

Public health relevance
Teichos proposes an improved treatment of Hemophilia A, relying on chemistry to synthesize the core structure of a heretofore inaccessible biomolecule that provides a unique approach for immunotherapeutic applications: modified bacterial cell wall peptidoglycan, sPGN. An immune response attenuator sPGN produces anti- inflammatory activity at low doses in laboratory studies by blocking toll-like receptor signaling and diminishing up-regulation of costimulatory molecules. Proof-of-concept studies will evaluate this non-toxic immune response attenuator as a tolerizing vaccine adjuvant to provide significant improvements in Factor VIII replacement therapy outcomes for Hemophilia A patients.